Insights Into Immune-Related Diseases Born from Population Genomics

Summary
The fundamental role of the immune system is to distinguish self from non-self, and healthy from unhealthy
tissue. The ligands and receptors encoded by the major histocompatibility complex (MHC), the killer cell
immunoglobulin-like receptor (KIR), and the natural killer complex (NKC), interact to help accomplish this role.
Successful pathogen defense drives the genetic diversity of these regions but may also lower the threshold for
autoimmunity. At the extremes of this spectrum is HLA-B*27, which protects against certain chronic infections
but is also the major risk factor for spondyloarthritis (SpA) and acute anterior uveitis (AAU).
Spondyloarthritis (SpA) refers to inflammatory musculoskeletal diseases, axial SpA (includes ankylosing
spondylitis), psoriatic arthritis (PsA), colitis-associated arthritis, and reactive arthritis (ReA). Painful, inflamed
joints are a common feature of SpA. Progression of axial disease leads to spinal fusion and reduced mobility.
AAU, inflammation of the anterior chamber of the eye, commonly occurs in SpA patients, and can cause
blindness. Although recent therapeutic advances have improved symptom management, whether they also
improve long-term outcomes is controversial. The frequency of HLA-B*27 is high among these groups, especially
in axial SpA, with up to 90% carrying HLA-B*27. About 2 million adults in the United States have SpA, with an
estimated minimum of 44 million globally. Thus, SpA carries a significant health and economic burden, and there
is a pressing need to understand more about the underlying disease mechanisms.
The MHC region and KIR are associated with SpA. The receptor KIR3DL1 recognizes HLA-B*27 as a ligand,
but how this relates to SpA is unknown. Given the shared associations but distinct manifestations of SpA, PsA,
ReA and AAU, we hypothesize that the genetic polymorphism of KIR3DL1, in combination with the MHC,
determines risk for specific SpA subtypes. Although genome-wide association studies have contributed to
understanding the genetic landscape of SpA, the diversity of KIR and MHC limit the utility of these methods for
uncovering more precise allelic associations. The Norman Lab is uniquely equipped to answer how the genetic
diversity of the MHC, KIR, and NKC impacts SpA disease susceptibility and severity. In Aim 1, we will use our
sequencing and bioinformatics approach to analyze these loci at high throughput and resolution from a total of
3,335 patients and 4,165 controls, with additional replication cohorts. Our cohort includes patients with axial SpA,
PsA, colitis-associated arthritis, ReA, and AAU. We will generate per-individual haplotypes and fine-map the
associations and interactions underlying SpA. In Aim 2, we will focus on the relationship between KIR3DL1 and
HLA-B*27, by investigating how KIR3DL1 allotypes impact NK cell responses in axial SpA. In Aim 3 we will apply
our targeted long-read sequencing methods to the extended MHC region and develop a method to reliably infer
allele-specific expression of MHC, KIR, and NKC from single-cell RNA sequencing. Through these Aims, we will
supply in-depth genetic analysis of MHC, KIR, and NKC in SpA, determine how KIR3DL1 allotypes impact NK
cell function in disease, significantly advance the field with reference haplotypes and innovative bioinformatic
methods, and provide a model for how to elucidate HLA/KIR associations in general.

Public health relevance
Narrative The human major histocompatibility complex (MHC) that encodes essential products of innate and adaptive immunity is extremely polymorphic, with wide-ranging consequences for immune-mediated disease. The MHC allele HLA-B*27 is highly associated with multiple syndromes, including the spondyloarthritis group of inflammatory musculoskeletal disease, and acute anterior uveitis, a potentially blinding eye inflammation. We will investigate how the combinatorial diversity of MHC and NK cell receptors impacts HLA-B*27-associated syndrome pathogenesis.